Neighborhood and digital immersion effects on PrEP adherence through a digital intervention in young sexual and gender minorities who have sex with men

Project Summary
Young sexual and gender minorities who have sex with men (YSGMSM) carry a disproportionate burden of the
HIV epidemic in the United States, yet Pre-Exposure Prophylaxis (PrEP) uptake and adherence has been
inadequate for these groups. Research into HIV syndemics has illuminated the importance of social and
structural factors for HIV risk, yet the research into HIV syndemics for YSGMSM has been limited to individual
level survey measures. A parallel line of research has used multilevel models to explicitly model neighborhood
factors, however no research to date has applied this modeling technique to understand the direct relationship
between social and structural neighborhood factors and PrEP adherence. Similarly, immersion in digital spaces
(e.g., consumption of social media) can influence HIV risk as well. Despite interventions for PrEP uptake and
adherence being increasingly delivered through digital devices, some of which utilize digital support
communities and the growing culture of digital communication among youth, including YSGMSM, no studies to
date have characterized how digital immersion influences PrEP adherence through a digital PrEP intervention.
Finally, it has been shown that joining non-digital support groups can mitigate neighborhood factors in
YSGMSM and reduce sexual risk behaviors suggesting that a digital PrEP intervention might have the same
capability but with more reach. For these reasons, this research will examine how convergent digital and
neighborhood factors impact PrEP adherence in YSGMSM by leveraging iTech’s P3 study, an NICHD-funded
randomized controlled trial (RCT) to improve PrEP adherence among YSGMSM. This three arm RCT is
designed to assess the effectiveness of P3 and P3+ to improve PrEP adherence among 246 16-24 year-old
YSGMSM across nine US study sites. The study collects residential zip code, allowing for examination of
neighborhood effects on PrEP adherence. Through mentored training in social and structural neighborhood
determinants of PrEP adherence in YSGMSM, multi-level models, mediation analysis, causal inference, and
professional development activities, the proposed F31 will achieve the following specific aims: 1) Characterize
how neighborhood syndemic risk relates to PrEP adherence in YSGSM, 2) Identify how immersion in digital
spaces and communities outside P3’s intervention influence engagement inside P3’s intervention, and
subsequent PrEP adherence, 3) Determine how the P3 intervention condition attenuates the relationship
between syndemic neighborhood and digital immersion factors’ impact on PrEP adherence. These aims will
enrich our understanding of how digital and neighborhood factors impact PrEP adherence, a critical step in
precision preventative health against HIV for YSGMSM. This aligns NICHD priorities for adolescent HIV
prevention with the Ending the HIV Epidemic in the US by 2030 Initiative.

Public health relevance
Project Narrative Young sexual and gender minorities who have sex with men (YSGMSM) carry a disproportionate burden of the HIV epidemic in the United States, yet Pre-Exposure Prophylaxis (PrEP) uptake and adherence has been inadequate for these groups despite evidence that it is safe and effective at reducing HIV transmission for YSGMSM. Syndemics theory is used to characterize convergent and mutually reinforcing social (e.g., race), structural (e.g., neighborhood poverty), and digital (e.g., social media consumption, access to internet) factors impacting HIV risk in YSGMSM. This proposal incorporates this syndemics approach into iTech’s P3 study, an NICHD-funded RCT to improve PrEP adherence among YSGMSM, to understand how convergent digital and neighborhood factors impact PrEP adherence in YSGMSM.